Risk, Resilience, and Recovery: A Longitudinal Mixed-Method Study Examining the Role of Peer Relationships in Pediatric Pain

Project Summary/Abstract
Pediatric chronic pain is a critical public health problem, affecting up to a third of adolescents and contributing
to significant emotional distress, poor sleep, and difficulties in social functioning. These difficulties include
social isolation, friendship instability, and high rates of peer victimization both on and offline. Whether peer
relationship problems are a cause, correlate, or consequence of chronic pain is largely unknown. Although
research has long demonstrated links between social pain (e.g., social exclusion, loneliness) and physical
pain—little research has examined the prospective, daily, or chronic impact of peer relationship problems on
pain persistence and pain-related disability in childhood. Further, no research has examined how positive peer
relationship factors (e.g., social connectedness, social support) may promote recovery or protect against the
development of disabling pediatric chronic pain. The objective of the proposed research is to identify specific
peer relationship processes that influence pain persistence, exacerbation, and recovery in a cohort of 450 early
adolescents (ages 11-14) at risk for developing chronic pain (i.e., youth seeking treatment for an acute pain
problem). Longitudinal studies that model the trajectories of peer relationship processes are needed to
establish temporal relationships and disentangle social risk and protective factors from outcomes. If peer
relationship factors contribute to pain persistence and pain-related disability, improving these relationships
should become an immediate goal of both prevention and intervention efforts. Here we combine 1) a large-
scale longitudinal cohort design, 2) comprehensive assessment of peer relationship processes and pain, and
3) a model-based approach to determine whether and how specific peer relationship processes (e.g., social
exclusion, cyber-victimization, social connectedness) contribute to pain outcomes in at-risk youth during the
critical transition from early to middle adolescence (Aims 1 and 2). Electronic daily diary monitoring of peer
victimization experiences and pain, incorporating objective assessment of social media use and sleep, will be
combined with qualitative interview data to characterize the temporal dynamics between peer victimization,
social media use, shared comorbidities, (i.e., poor sleep, low mood) and pain outcomes (Aim 3). Our broad
hypothesis is that peer relationship problems will contribute to pain persistence and disability, directly and
indirectly (through mood and sleep mechanisms)—and that these effects will be mitigated by the presence of
strong social support and social connectedness. The proposed methodologically rigorous mixed-methods
investigation of peer relationship trajectories from early to middle adolescence will advance our understanding
of the specific peer relationship processes that contribute to pain risk and resilience in childhood. Mechanistic
insights regarding the role of modifiable social contextual factors will influence clinical practice guidelines and
the development of preventative interventions designed to reduce risk of high impact chronic pain in childhood
and beyond.

Public health relevance
Project Narrative PUBLIC HEALTH RELEVANCE: There is a remarkable increase in the incidence of chronic pain during the transition from early to middle adolescence, a developmental period that is also characterized by the heightened significance and salience of peer relationships and experiences on and offline. Although peer relationship difficulties are commonly observed in youth with chronic pain, whether these difficulties are a cause, correlate, or consequence of pediatric chronic pain is unknown. The long-term goal of this research program is to identify specific peer relationship processes (e.g., traditional and cyber-victimization, social support, and social connectedness) that influence pain persistence, exacerbation, and recovery in a cohort of youth at-risk for chronic pain, such that more developmentally appropriate and effective prevention and intervention programs can be created.